Regulation of Retinal Development by RNA molecules

PROJECT SUMMARY
The prevailing hypothesis in biology is encapsulated by the ‘central dogma’, which posits that our heritable
genetic traits are encoded by DNA, transcribed into an RNA intermediate, and translated into functional
proteins. However, this model fails to incorporate the contributions of the prevalent expression of non-coding
RNA transcripts. Our recent profiling of the developing retina of humans and mice highlighted widespread and
temporally dynamic expression of long non-protein coding RNAs (lncRNAs). lncRNAs play essential roles in
the regulation of transcriptional and epigenetic programs during cell fate decisions, including those of the
developing retina. One mechanism by which lncRNAs function is through initiating scaffolding complexes with
proteins and DNA, including interactions with transcription factors to modulate transcriptional activity. We
hypothesize that retinal expressed lncRNAs function to control retinal gene regulatory networks, in part through
interaction with transcription factors. To test this hypothesis, we first propose to utilize both gain-of-function and
a novel loss-of-function models to examine the effect of the lncRNA Gm11454 expression on retinal progenitor
cell development and differentiation. Additionally, we will assess the trans functions of Gm11454 in virally
mediated rescue experiments. Secondly, the sites of DNA-RNA interaction are determined through Chromatin
Isolation by RNA Precipitation. The functional significance of sites of DNA-RNA binding will be determined by
assessing changes gene expression and chromatin accessibility because of altered Gm11454 expression.
Thirdly, we will characterize RNA-transcription factor interactions. Preliminary results identified Gm11454-
transcription factor interactions. We will test the significance of RNA-binding by transcription factors through
genome-wide profiling of RNA-guided transcription factor binding to DNA. Finally, we will implement a novel
Digital Affinity Profiling via Proximity Ligation approach to identify novel RNA-interactions of retinal transcription
factors, performing extensive validation techniques. These studies will provide important insights into the
biomolecular regulatory mechanisms by which RNA transcripts control retinal gene regulatory networks.
Importantly, these studies aim to provide novel insights into the molecular consequences of altered (lnc)RNA
expression during retinal development and disease.

Public health relevance
PROJECT NARRATIVE Greater than 75% of the human genome is transcribed, yet only 2% of genomic sequence is transcribed into protein coding RNA transcripts. Estimates suggest 50-90% of disease-causing mutations are located within noncoding sequences, suggesting non-protein coding RNA transcripts significantly contribute to disease pathogenesis. Upon completion, our study will provide insights into the mechanisms by which noncoding RNA transcripts regulate retinal development and visual function, including providing insights into the prevalence and function of transcription factors binding to RNA.